Cell and Molecular Biology Research Program

The Cell and Molecular Biology (CMB) Program of Winship Cancer Institute of Emory University (Winship)
conducts highly innovative basic and translational research with a strong focus on catchment area priorities.
Formed in 2019 by restructuring the previous Cancer Genetics and Epigenetics (CGE) and Cancer Cell Biology
(CCB) programs into one research program, the scientific themes of CMB are: (1) Cancer Cell Metabolism aims
to unravel the molecular mechanisms underlying metabolic alterations in cancer cells to exploit for novel
therapeutic interventions; (2) Cell Survival and Death Mechanisms aims to understand the mechanisms by which
cancer cells evade cell death and to identify novel therapeutic approaches to promote cell death; (3) Mechanisms
of Invasion and Metastasis aims to identify the key mediators of tumor growth and metastasis, and discover
mechanisms that drive tumor cell adhesion, communication, invasion, and metastasis, and; (4) Gene Regulation
aims to decipher the basic mechanisms by which genetic or epigenetic influences regulate gene expression and
contribute to oncogenesis. CMB leaders foster a rich research training environment contributing to the promotion
of biomedical scientific careers from middle school through college. CMB maintains research focus on Winship’s
catchment area priorities through strong engagement with Community Outreach and Engagement (COE). Under
the leadership of Wei Zhou, PhD (leader) and C.K. Qu, MD, PhD (co-leader), the new CMB Program includes
46 core members representing 16 departments within the School of Medicine (SOM), School of Public Health,
and College of Arts and Sciences. This highly collaborative group of researchers have published a total 317
cancer-relevant scientific articles during the current funding period with 42 (13%) intra- and 139 (44%) interprogrammatic,
234 (74%) inter-institutional collaborations, and 94 (30%) published in journals with an impact
factor ≥10. As of December 31, 2021, CMB members held $10.0 million (direct) in annual cancer-relevant
research funding, of which $9.4 million is peer-reviewed with $4.5 million (47%) from the NCI. Notable
accomplishments during the funding cycle include 21 new R01 grants (11 NCI) that have developed into impactful
CMB scientific contributions including: i) lestaurtinib as a new MAST-1 inhibitor, ii) innovative “leader cell”
identification for anti-metastasis target discovery and iii) advancement of pilot grant funded basic research with
a novel Drosophila glioma model to a phase I/II clinical trial, and iv) pre-clinical development of the MCL1 inhibitor
AZD5991 leading to first-in-human clinical trial at Winship. CMB has greatly benefited from Winship’s shared
resources, infrastructure for basic and translational research, $2.1 million in pilot grant support during the present
funding period, and engaging team science environment with CMB member leadership in P50 Lung SPORE and
new P01 (May 2022) for research on LKB1- mutated lung cancer. CMB is poised to make transformational
contributions through understanding cellular and molecular mechanisms underlying cancer and drive novel
therapeutic approaches.